Cancer Center Administration

We propose to purify SARS-CoV-2 proteins to build a plate or filter-based array for rapid assessment of antibody responses. Proteins will be expressed in E. coli and purified as recombinant proteins. The arrays will initially be constructed manually using a vacuum blot system or ELISA plates. If arrays prove useful, a robotic system will be retooled. In addition to proteins already under study, we would expand our library to include all of the smaller open reading frames, especially proteins E and M, which are 100% conserved with SARS. The SARS-CoV-2 proteome can be covered in a 30 protein array. These arrays would then be used to ask novel questions about the development of the immune response in different patient cohorts, including cancer patients.

Public health relevance
PROJECT NARRATIVE This Cancer Center Support Grant is requested to provide support for the critical infrastructure and shared resources needed by Lurie Cancer Center investigators to develop approaches and methods for cancer prevention, treatment and control.